METTL16 and S-adenosylmethionine cycle in KSHV infection

Programmed metabolic pathways provide the building blocks, energy and signaling molecules required for viral
infection. Kaposi’s sarcoma-associated herpesvirus (KSHV) is the causal agent of Kaposi’s sarcoma (KS) and
several other malignancies. While KSHV lytic infection is responsible for viral spread and KS initiation, latent
infection is essential for viral persistence and long-term KS development. We have previously found that KSHV
reprograms metabolic pathways and N6-methyladenosine (m6A) epitranscriptome during infection. Significantly,
KSHV reprogramed m6A epitranscriptome rewires multiple metabolic pathways during both latent and lytic
infections. In particular, KSHV LANA and RTA interact with and alter the function of m6A writer protein METTL16
to reprogram the methionine/S-adenosylmethionine (SAM) cycle, maximizing both viral latent and lytic infections,
respectively. Genetic or chemical inhibition of METLL16 or its key target gene MAT2A disrupts KSHV latency
and promotes viral lytic infection as a result of inhibition of the SAM cycle. Our Central Hypothesis is that KSHV
manipulates cellular methionine/SAM cycle to maximize both latent and lytic infections by hijacking METTL16 to
reprogram specific m6A marks. We will identify KSHV-regulated METTL16-specific m6A marks at a single-base
resolution during latent and lytic infections and determine their mechanisms of regulation of the SAM cycle (Aim
1), delineate the mechanisms of regulation of KSHV latent and lytic infections by the SAM cycle (Aim 2), and
define the mechanisms by which KSHV hijacks METTL16 to deregulate m6A epitranscriptome and the SAM
cycle during latent and lytic infections (Aim 3). We have assembled a multidisciplinary team with diverse
expertise in KSHV biology, KS pathology, metabolism, proteomics and computational biology for addressing the
complex issues in this project. This project is highly innovative as it will converge the emerging advancements
in epitranscriptomics and metabolism fields, and define their roles in KSHV infection. The project is highly
significant as the outcomes will reveal novel mechanisms regulating KSHV latent and lytic infections, which will
lead to the discovery of novel therapeutic targets for KSHV-induced cancers.

Public health relevance
Project Narrative Kaposi’s sarcoma-associated herpesvirus (KSHV) causes several human cancers including Kaposi’s sarcoma, primary effusion lymphoma and multicentric Castleman’s disease. These malignancies inflict morbidity and mortality to the society in US and worldwide. This project will investigate the mechanisms of KSHV reprograming of epitranscriptome and metabolic pathways during infection, and identify potential therapeutic targets for developing novel prevention and treatment approaches.